CELLULAR AND MOLECULAR PROFILES OF BENZO(A)PYRENE INSULATED DEVELOPING T CELLS

The objective is to clarify disrupted cellular and molecular events during fetal ontogeny by which carcinogenic pollutants lead to immune deficiencies. The hypothesis is that chemical carcinogens alter surface receptors of immune cells that can result in reduced recognition of foreign antigens. Altered surface molecules include T cell receptor (TCR), CD4 (helper) and CD8 (effector), and CD3 essential in T cell activation. Intermediates of metabolized Benzo (a)pyrene [BP-7, 8-diol- 9, 10-eposide (BPDE)] and aminofluorene (AF-OH-N) adduct to DNA and may alter T cell antigen profiles. The specific aims are; 1. To evaluate T cell profiles (including those recognizing the major histocompatibility complex and antigen), in cells purified by magnetic activated cell sorting (MACS) and by fluorescence activated cell sorting (FACS). 2. To assay cellular function by standard immunoassays including the mixed lymphocyte response (MLR), and the antibody (plaque) forming cell (PFC) response in cloned and purified cells. 3. To detect BPDE- and N-OH-AF- DNA adducts in purified (MACS; FACS) and cloned T cells after in vivo or in vitro exposure to the carcinogens as this correlates with function (helpers; cytotoxic/suppressors). 4. To determine alterations in variable TCR DNA regions after fetal BP insult by the polymerase chain reaction, and the influence on TCR antigens. 5. To characterize the effect of maternal thymus after midpregnancy BP-exposure on progeny immune status employing maternal thymectomy and thymic implants on progeny MLR and PFC response. These studies will give insight on mechanism(s) of immune deficiency attributed to these carcinogens. In future studies we should be able to relate our findings to immune disability in responding against deleterious agents, including tumor antigens and infectious material.